Microtemporal Processes Underlying Health Behavior Adoption and Maintenance

PROJECT SUMMARY
This application responds to PA-20-272 Administrative Supplements to Existing NIH Grants and Cooperative
Agreements (Parent Admin Supp Clinical Trial Optional). It will make significant contributions to Intensive
Longitudinal Health Behavior Network (ILHBN) cross-study projects by (1) sharing relevant data collected
through the TIME study to support four cross-network projects as well as future work with shared datasets, and
(2) leading the effort on a cross-network project to investigate reliability and variance in affect data collected
across ILHBN studies. To date, the ILHBN has collectively generated rich intensive longitudinal data (ILD) and
explored state-of-the-art methodologies for analysis of such health data. However, data sharing across and
outside of individual projects remains limited due to budgetary and personnel constraints that prevent some sites
from preparing their data to share within the ILHBN, as well as the additional challenges brought on by the
pandemic that have required each team to focus more effort than anticipated on their own data collection. The
richness of the ILD collected means that there are many possibilities for secondary analyses and modeling efforts
that are beyond the scopes of the parent projects if data harmonization and sharing can be achieved across the
projects. The projected sample size across all studies is 2210 participants and 854,220 person days across all
sites. This is an unprecedented dataset that could support a large body of future work on the use of ILD for
behavioral measurement, including important methodological results about how this new field might move
forward. Gaps in knowledge about optimal ways to measure to better understand affect dynamics can be filled
by pooled analysis from our network. Improving methodologies to capture dynamic emotional experiences in
naturalistic settings can help researchers elucidate the affective processes underlying various behaviors and
disorders. This proposed administrative supplement offers a unique opportunity to contribute to cross network
projects examining a variety of impactful questions about longitudinal changes in health behavior and makes
contributions to improved understanding of the psychometric properties of affect items measured through EMA
across many occasions.

Public health relevance
PROJECT NARRATIVE This administrative supplement offers a unique opportunity to lead and contribute to data sharing projects that combine intensive longitudinal data collected through seven NIH funded studies participating in the Intensive Longitudinal Health Behavior Network (ILHBN). Given the diversity of data streams across time scales, geographical regions, and study populations, this proposed pooled dataset and analyses will have the potential to examine impactful questions about longitudinal changes in health behavior.